Maintaining and enriching the Infants Environmental Health Study (ISA)

Understanding the potential health effects of pesticides is difficult due to the episodic nature of
exposure and the lack of individual’s knowledge regarding their personal exposure. The ISA Cohort
study in Costa Rica is a community-based cohort of 350 mothers and their now 5-7 year old children
living in Matina County, Costa Rica, a banana growing region for the country. These individuals
are exposed to a variety of different chemicals as used in agriculture, mainly banana production,
vector control, and pasture, including mancozeb, chlorpyrifos, pyrimethanil, thiabendazole,
cypermethrin, and 2,4-D. Exposure to these and other pesticides, as well as manganese (a component
of mancozeb), has been measured through biological and environmental monitoring of the cohort for
the past six years. To date, investigators have been funded to assess growth and neurobehavioral
outcomes associated with pre- and post-natal exposure to these pesticides, oxidative stress, and
respiratory and allergic outcomes in mothers and children. The ISA cohort provides critical
information to assess the potential human health effects of pesticides as these same pesticides are
used in the US as well as Costa Rica. This proposal will strengthen the ISA cohort for the
long-term by: 1) creating a more consistent outreach program to inform the cohort members as well
as their communities, civil society organizations, governmental organizations and private sector
about study findings on a regular basis; 2) updating participant medical history including
neurobehavioral and respiratory outcomes and collecting biological samples every two years; 3)
establishing more complete data documentation to allow for easier collaboration and data sharing;
4) providing long term specimen storage in Costa Rica; and 5) enhancing understanding of pesticide
exposure in the cohort and community through aggregation of available exposure data for cohort
participants, validation of urinary biomarkers with environmental sampling, air monitoring of
pesticides at primary schools situated in the study area, and statistical approaches to manage the
complex exposure data. This proposal focuses on a community-engaged model to enhance long term
follow-up by collecting and report data relevant to the community on a routine basis.

Public health relevance
Narrative The ISA cohort is a group of 350 mother?child pairs from Matina County, Costa Rica, a banana growing region. The cohort provides a unique opportunity to study the potential health effects of pesticides used both in Costa Rica and the United States. To better maintain this cohort, we plan to: use a community?engaged framework to build enthusiasm for the study; update and maintain a rigorous data documentation program; and to continue to measure pesticide exposure in this community.